The Heart Outcomes for Pregnancy Expectations Study

Project Abstract/Summary
The US not only has the highest rate of maternal mortality in the developed world but is the only country in which
this rate is rising. It is also notorious for marked racial disparities, with black maternal deaths being 3-4 times
greater than that of white pregnant people. While affecting only 4% of pregnancies, cardiovascular disease
(CVD) accounts for up to 30% of maternal deaths and yet there no is evidence about how best to stratify risk or
deliver care in this population. While cardio-obstetrics (COB) clinics have emerged, with encouragement and
support from both the AHA and ACOG, these have been implemented with very heterogeneous structures. In
collaboration with a large network of COB clinics, we have identified 5 structural components of care that have
been variably deployed and for which further evidence is needed to define whether any of these components
independently improves outcomes. Along with 33 partner sites, we propose the first-ever, US-based, prospective
evaluation of 1000 (40% minorities) consecutive pregnant people with CVD to identify clinical, patient-reported
(including perceived discrimination) and structural characteristics of care associated with adverse pregnancy
outcomes (APO), maternal adverse cardiac outcomes (MACE), neonatal adverse clinical events (NACE) and
quality of life (QoL). Our study will address both the exceedingly high prevalence of adverse outcomes and racial
disparities in pregnancy by: 1) Identifying patient characteristics, at the time of prenatal care initiation and
throughout pregnancy, associated with APOs, NACE and MACE with a special focus on racial disparities; and 2)
By adjusting for these factors, define the independent association of alternative structures of care so that future
COB clinics can be developed to optimize outcomes. We will prospectively collect detailed patient-level
variables, and the first ever serial assessment of quality of life data, from initial COB presentation and throughout
pregnancy, delivery and 1 year postpartum. This will be the first national, multisite, prospective study of pregnant
people with CV disease ever conducted in the US and is critically important to address our country's marked
disparities and rising maternal morbidity and mortality. This work will be the foundation for future RCTs. To
accelerate the translation of our findings to clinical practice, we have actively engaged dissemination partners
from the design phase of the program to join us in the analysis and interpretation of our findings so as to
accelerate their efforts to improve maternal care.

Public health relevance
Project Narrative for HOPE study: Women with cardiovascular disease (CVD) have the highest risk of adverse maternal and neonatal outcomes and in the US, which has the worst maternal outcomes and greatest racial disparities in the industrial world, there is a lack of evidence estimating patients’ risks or how best to structure Cardio-Obstetrics (COB) care. The HOPE study has coalesced the nation’s top COB experts to prospectively enroll 1000 pregnant women with CVD to identify patient risk factors for adverse clinical and quality of life outcomes, and to rigorously test what structures and processes of care best optimize outcomes. Through our dissemination partners and engagement with professional organizations and patient-advocacy groups, we will develop novel strategies to elevate the care of pregnant people with CVD and reduce disparities by defining the optimal structures of COB care, guiding the development of performance measures for quality, and by supporting the creation of novel risk prediction models to support the creation of risk-based protocols to optimize outcomes.